Addressing Physical Activity Among Adults with Vision Impairment

PROJECT SUMMARY
People with vision impairments or blindness routinely face substantial challenges in everyday living
that can significantly limit their participation in physical activity and exercise important for managing weight
and overall health. While there is a growing amount of scientific literature documenting physical inactivity
and increased time spent in sedentary behaviors among people with vision impairments, there remains a
dearth of health promotion research specifically studying this vulnerable population in comparison people
with adequate sight. Further lacking is the availability of evidence-based physical activity-based health
promotion programs tailored to the unique challenges experienced by individuals with a vision impairment.
Our preliminary findings clearly support the significance of this health disparity within this vulnerable
population.
As such, this timely project will address this health disparity by: (1) adapting an evidence-based
physical activity behavior change intervention tailored to the unique challenges of adults living with a vision
impairment and (2) establishing feasibility, patient satisfaction, and preliminary efficacy of the adapted
intervention for increasing physical activity intensity and duration along with other health outcomes among
adults with vision impairments. Our research will also be informed by an Advisory Board consisting of key
stakeholders (e.g., adults living with a vision impairment; vision-related organizations involved in advocacy,
policy, and service; along with our investigative scientific team).

Public health relevance
PROJECT NARRATIVE People with living with a vision impairment (VI) are not immune to problems engaging in routine physical activity and exercise necessary for health benefits and in fact, research shows that this vulnerable population is disproportionally at greater risk for physical inactivity, sedentary behaviors, and subsequent chronic health complications (e.g., obesity; hypertension; cardiovascular disease) compared to those with adequate vision. To urgently address this health disparity, an evidence-based physical activity behavior change intervention will be modified and evaluated to motivate and empower people with a VI to gradually increase physical activity behaviors to levels associated with health benefits and the prevention of secondary health conditions. Individuals with a VI will improve physical activity duration and intensity which will positively impact their everyday functioning, emotional well-being, sleep quality, vision-related quality of life, and social participation.